RETROVIR IN PATIENTS INFECTED WITH HIV WHO ARE ASYMPTOMATIC

The purpose of this study is to determine the safety and tolerance of chronic administration of retrovir in HIV infected adult patients without clinical manifestations of the disease.